Genetic and developmental mechanisms that underlie craniofacial (co)variation

Abstract/Summary:
The vertebrate craniofacial skeleton is a dynamic organ that arises and is maintained through an
intricate balance of genetic and environmental inputs. Disruptions to either can lead to deleterious
health outcomes. While significant progress has been made toward understanding the genetic and
cellular mechanisms that underlie early craniofacial patterning, much less is known about the basis for
craniofacial variation that manifests over extended periods of development, and depends upon the
environmental context in which it occurs. Whether it's the physical interactions between cells and
tissues within the developing embryo, or the mechanic forces imposed on the system, these contexts
will determine how genetically-encoded systems unfold over time to determine craniofacial geometry.
Implicit to these ideas is feedback in the system. Feedback is how disparate developmental units
come together to form integrated functional systems - e.g., reciprocal signaling between adjacent but
developmentally distinct tissues. It is also necessary for normal growth and homeostasis in kinetic
systems - e.g., progenitor cells must sense environmental inputs, including mechanical load, and adjust
developmental processes accordingly. Broadly speaking this proposal seeks to understand how both
types of feedback are regulated at the genetic level. In doing so, three specific questions will be
addressed: (1) What are the genes that contribute to craniofacial shape? (2) Do they exert their effects
on more than one tissue, either via pleiotropy or as part of the same signaling pathway? (3) How do
these loci interact with the environment, via mechanosensing, to affect variation in facial form?
Cichlid fishes will be used as the experimental model, as they have undergone extensive
evolutionary modifications of their skulls and jaws in a very brief period of time, making them ideal for
genetic/genomic mapping. Cichlids are also well known for their capacity to remodel their jaws under
different foraging environment, but not all cichlids share this ability, and thus plasticity itself is
genetically determined and has diverged in this system. Cichlids therefore represent an ideal model to
identify and parse the genetic, environmental, and GxE effects that underlie craniofacial variability. This
proposal leverages these experimental attributes, and integrates advanced phenotypic, genotypic and
functional tools to provide a more holistic understanding of the mechanisms that underlie craniofacial
shape.

Public health relevance
Project Narrative: How the complex geometry of the vertebrate head is specified over development is an area of active investigation that is relevant to myriad areas of biology, from ecology and evolution, to genetics and development, to human health and disease. The work proposed here aligns squarely with this imperative, as it seeks to significantly expand our understanding of the genetic, developmental and environmental factors and interactions that participate in craniofacial development.